A unified eligibility application and determination system to increase Ryan White linkage to care and retention in care by reducing structural barriers and facilitating client engagement

Project Summary
Over 500,000 people diagnosed with HIV in the United States received health care and support
services through the RWHAP, including AIDS Drug Assistance (ADAP) programs in 2021. These
services are critical for attaining optimal HIV health outcomes among people with HIV, preventing
further transmission of the virus, and ultimately, ending the HIV epidemic in the United States.
Unfortunately, nationwide, only 81% of Ryan White eligible clients attended an HIV medical care visit
within 1 month of HIV diagnosis. Additionally, 22% of RWHAP participants are not retained in care,
resulting in suboptimal individual healthcare outcomes and ongoing virus transmission. This is due, in
part, to the difficulties associated with determining and maintaining eligibility for these programs, the
lack of a system to share eligibility status across the hundreds of HIV care providers across each state,
and an inability to share data that is critical to retention and adherence efforts. This creates delays in
access to care, clients falling out of care, and staffing inefficiencies caused by duplicate data entry.
Additionally, the fragmentation and unavailability of data makes it difficult for staff to identify and
re-engage clients that are falling out of care.
In this Direct to Phase II application, Groupware Technologies proposes to develop a new
collaborative eligibility platform that will support the application, determination, recertification, and
enrollment for all HIV service providers while also supporting the unique needs of the different
programs and individual providers. This will allow a client to complete a single eligibility application to
gain access to multiple programs while providing each program with the control that they need. It will
also integrate information from all agencies across the state so they can easily see, share, and manage
applications from all clients statewide, accelerate access to care, and coordinate client retention efforts.
To achieve these goals, this project has the following aims: (Aim 1) Develop a web-based
collaborative eligibility, enrollment, and ADAP management platform that is more functional and usable
than currently used methods; (Aim 2) Validate a decrease in the time required to determine eligibility
when using the platform; and (Aim 3) Validate an improvement in Linkage to Care, Retention in Care,
Viral Suppression, and Loss of Service Due to an Inability to Confirm Eligibility.
By achieving these aims, we will demonstrate that a collaborative eligibility, enrollment, and
ADAP/RWHAP management platform will improve key steps in the HIV care continuum while
addressing the state and local ADAP and RWHAP programmatic needs. We will validate this impact
with 2 statewide RWHAP Part B, including ADAP, implementations.

Public health relevance
Project Narrative Over 500,000 people with diagnosed HIV in the United States receive direct health care and support services through the Ryan White HIV/AIDS and AIDS Drug Assistance programs. However, 20% fall out of care each year, partly due to challenges with determining and recertifying eligibility and a lack of coordination and access to critical data across treatment providers. In this Direct to Phase II application, Groupware Technologies proposes to develop a new unified and collaborative eligibility, enrollment, and ADAP/RWHAP management solution and validate the impact on application determination times, linkage to care, retention in care, viral suppression, and loss of service due to an inability to confirm eligibility for 2 statewide implementations that include both RWHAP and ADAP programs and the associated hundreds of agencies that provide HIV care.